Enrichment Program

ABSTRACT: Enrichment Program
The Enrichment Program of the Washington University Diabetes Research Center (DRC) was established to
promote scientific exchange and collaboration among DRC investigators, as well as education and training for
young investigators in the area of diabetes and metabolism. The Enrichment Program is led by Carlos Bernal-
Mizrachi, MD, DRC Associate Director for Clinical/Translational Research and a member of the Internal
Advisory Committee. Overall, the Enrichment Program provides a venue for learning about the latest advances
in diabetes and its complications and catalyzes interactions among DRC scientists, with outside experts who
visit our program, and with other NIDDK-funded DRCs. The collaborations and mentoring fostered by
Enrichment Program activities have enhanced the productivity of investigators focused on discovery of
fundamental mechanisms leading to diabetes and its complications and discovery of new approaches to
prevention, treatment, and cure of diabetes.